Biometry Web Projects: Cancer Prevention Fellowship Program (CPFP) Application Sy

Cancer Prevention Fellowship Program (CPFP) Application System: The CPFP Application System is a website that allows individuals to apply online to the CPFP’s fellowship program and the NCI Summer Curriculum in Cancer Prevention. The fellowship application allows applicants to upload documents (e.g., personal statement of research goals, curriculum vitae) and to request supporting documentation (e.g. letters of reference) from individuals. Referees upload supporting documentation through the system and automated emails alert applicants as supporting documentation is received. Reviewers are randomly assigned applications to review and can score applications online. CPFP staff has specialized features to send reminders, process applications, calculate reviewer z-scores, and analyze application trends. The NCI Summer Curriculum in Cancer Prevention Application allows an applicant to complete an online application to attend one or both of the training courses held each summer: the Principles and Practice of Cancer Prevention and Control course and the Molecular Prevention Course. Applicants can upload documentation. Applications are evaluated by either the CPFP or the NCI Office of International Affairs.